O-O Bond Activation (and Formation) at Bimetallic Enzyme Active Sites

The overall goal of this proposal is to understand how dioxygen is activated by nonheme diiron
enzymes in metabolically critical transformations. These enzymes perform a remarkable range of functions,
including the biosynthesis of DNA (ribonucleotide reductase (RNR)), the hydroxylation of organic substrates
(soluble methane monooxygenase (sMMOH), toluene monooxygenase), the hydroxylation of the eukaryotic
initiation factor 5a to regulate eukaryotic cell proliferation (human deoxyhypusine hydroxylase (hDOHH)), the
biosynthesis of antibiotics (CmlA, CmlI), and the production of biodiesel (cyanobacterial aldehyde
deformylating oxygenase (cADO)). Important project goals are to understand the roles of the initial diiron(II,III)-
superoxo species and the subsequently formed diiron(III)-peroxo intermediates in substrate oxidation, how the
latter can be converted to corresponding high-valent iron-oxo species that often serve as the key oxidants for
substrate transformation, and to describe the structural, electronic, and reactivity properties of the high-valent
intermediates. These goals will be accomplished by a combination of biochemical and biomimetic approaches.
Our biochemical effort focuses on the diferric-peroxo intermediates (P) of hDOHH and CmlI we found to
have different core structures from the carboxylate-bridged intermediates of sMMOH and RNR. With as many
as four different P species to compare kinetically and spectroscopically, we aim to shed light on how these
structural differences lead to the reactions their respective enzymes catalyze.
Our biomimetic effort will focus on characterizing the various diiron-O2 intermediates listed above to
gain detailed insight into their electronic structures and their oxidative reactivity. For example, can a
diiron(II,III)-superoxo species hydroxylate toluene like toluene-4-monooxygenase? Is it possible for a diiron(III)-
peroxo species oxidize C–H bonds to model a hydroxylase and also mimic the action of cADO in the oxidative
deformylation of aldehydes? What factors favor one reaction over the other? Most importantly, how are diferric-
peroxo intermediates converted into the high-valent diiron oxidants that carry out the most difficult substrate
oxidations. These latter complexes are also critical to our efforts to clarify the nature of the high-valent diiron
core in the methane-hydroxylating enzyme intermediate sMMOH-Q using new spectroscopic techniques.
Our biomimetic efforts will be extended to the synthesis of Fe–O–Mn and Fe–O–Ce complexes. The
Fe–O–Mn complexes mimic high-valent intermediates of the ribonucleotide reductase from the parasite
Chlamydia trachomatis and the related R2lox enzymes found in pathogenic bacteria. Understanding the
difference in the reactivity properties of high-valent FeFe and FeMn complexes may contribute to the
development of better methods for treating infections from such human pathogens. The Fe–O–Ce complexes
will help us understand the O–O bond formation mechanism of iron-catalyzed water oxidation by CeIV, which
we propose to be just the reverse of the reaction sequence used by the diiron enzymes for dioxygen activation.

Public health relevance
Nonheme diiron enzymes perform a variety of metabolically critical functions that require O2. For example, ribonucleotide reductase is a key enzyme that controls DNA biosynthesis, while deoxyhypusine hydroxylase is required for the formation of mature eukaryotic initiation factor 5a that is essential for cell proliferation. Understanding how these enzymes work can lead to the development of new drug strategies for treating cancer, AIDS, and infections by human pathogens like Chlamydiae.